Immersive Virtual Reality to Improve Outcomes in Patients with Stroke: A Pilot Study

Background. Over the last decade, Virtual Reality (VR) has emerged as a cutting-edge technology in
stroke rehabilitation. VR is defined as a type of user-computer interface that implements real-time
simulation of an activity or environment allowing user interaction via multiple sensory modalities. VR
interventions in a stroke population have been shown to be equivalent to usual care therapies and to
enhance motor recovery when utilized as an adjunct. Significance/Impact/Innovation. This research will
advance knowledge in rehabilitation research by testing state-of-the-art immersive 3-dimensional VR
technology with the post-acute stroke Veteran population. The proposed project addresses: (1) the RR&D
goal of maximizing functional recovery, (2) interest in non-pharmacological activity-based interventions for
pain, and (3) supports modernization of the Veterans’ Health Administration by incorporating technology-
assisted rehabilitation.
Specific Aims. (1) Determine the feasibility and tolerability of using a therapeutic VR platform in an
inpatient comprehensive stroke rehabilitation program and (2) Estimate the initial clinical efficacy, or effect
size, associated with the VR platform using APPS for distraction and upper extremity exercise for
Veterans post-stroke.
Methodology. Prospective within-subject pre-post pilot and survey study designs will be used. The
target populations are (1) clinical staff who work on the Comprehensive Interdisciplinary Inpatient
Rehabilitation Program (CIIRP) at the James A. Haley Veterans’ Hospital (JAHVH) in Tampa (sample size
N=10) and Veterans who are inpatients in the CIIRP (sample size N=10). The VR intervention consists of
wearing a head mounted display that plays APPs ranging from music and nature views for pain distraction
to more challenging strengthening and coordination activities such as playing the piano virtually. The
intervention will last four weeks. The analytic approach will use descriptive statistics and qualitative
methods. Aim 1 will administer a survey with open and closed ended questions to clinicians to examine
the feasibility of successfully integrating a VR intervention into the flow of usual care. Feasibility constructs
include adaptability (can VR intervention be adapted to an inpatient unit), patient need (do Veterans like
and benefit from the intervention), and staff comments/impressions. Responses for each construct will be
entered into an excel spreadsheet, one tab for each construct. Responses will then be grouped by similar
content. Results will be reported as themes and subthemes. Aim 1 will also track patient VR tolerability by
documenting and discussing patient complaints and adverse events. Tolerability data will be extracted
from meeting minutes and grouped by similar occurrences. Results will be reported as themes and
subthemes. Aim 2 will estimate effect sizes and degree of precision for upper extremity neurologic
recovery, hand dexterity, and pain outcomes measured pre and post VR intervention. Neurologic recovery
is measured with the Fugl-Meyer Assessment of Motor Recovery after Stroke-Upper Extremity, dexterity
is measured with the Action Research Arm Test, and pain is measured with the Pain Outcomes
Questionnaire-VA. Because standard scores do not necessarily translate to meaningful clinical differences
(improvements), we will identify the proportion of subjects who experience the minimal clinically important
difference (MCID). Metrics will also be compared across outcomes.
Next Steps/Implementation. Our next step is to work with our Program Partner in the Physical Medicine
and Rehabilitation Office to conduct a large multi-site clinical trial that will incorporate the lessons learned
from this feasibility pilot study to test the efficacy of a VR intervention in inpatient rehabilitation and
transition to home evironments.

Public health relevance
Over 15,000 Veterans are treated by the VA for stroke each year. A stroke means that part of the brain dies. Many people who have a stroke have difficulty with moving their arm, using their hand, and they have pain. Virtual reality is a video-game based treatment that may help people with stroke improve in these areas. Virtual reality involves using a computer and goggles to make a person feel like they are in a different world with new sights and sounds, relaxing on a beach where there is no pain, or playing the piano. In virtual reality, stroke patients can practice movement in a safe and motivating environment. For example, a person with stroke who has weakness in his/her arm can safely reach for plates in a virtual cupboard. In a virtual environment, the plates can’t break. This study will help us to determine if people with strokes who are treated with virtual reality like it, and if they have less pain and better movement.